Role of Pacs2 in central nervous system myelination

Project Summary Myelination of the central nervous system (CNS) by oligodendrocytes (OLs) is essential for the development and function of the CNS. Myelin develops in the CNS as OL precursor cells (OPCs) differentiate into OLs, highlighting OL differentiation as a key event for CNS myelination. Myrf is a master transcription factor of OL differentiation and CNS myelination. Conditional knockout (cKO) of Myrf in OL lineage cells leads to complete arrest of OL maturation and lethal dysmyelination. Apparently, the indispensable role of Myrf reflects that of Myrf target genes in the myelination process. To find novel Myrf targets that may play a critical role in OL development, we performed an RNA-seq experiment where we acutely knocked out Myrf in differentiating OLs. As expected, the expression of many genes that are crucial for OL differentiation and CNS myelination went down significantly upon acute Myrf knockout. Unexpectedly, however, a gene ontology analysis revealed that Myrf specifically activates the expression of genes related to cell projection, synapse, and intracellular transport in pre-myelinating OLs. Further, it suggested that molecular machineries involved in axon elongation may propel the growth of OL processes, which contact axons and eventually form myelin sheaths. Studying genes that belong to these categories may provide a novel insight into OL differentiation and CNS myelination. In this regard, we decided to focus on Pacs2 (phosphofurin acidic cluster sorting protein 2), which was significantly down-regulated upon acute Myrf knockout. Pacs2 is a multifunctional protein that plays an important role in diverse processes such as endoplasmic reticulum-mitochondria contact and cargo sorting and transport. PACS2 mutations have been linked to human neurodevelopmental disorders, including a syndromic form of autism. Remarkably, Pacs2 is mainly expressed by OLs in the CNS. Together with the RNA-seq finding that Pacs2 is a putative Myrf target, these observations suggest that Pacs2 may be required for OL development and CNS myelination and that PACS2 dysfunction in OL lineage cells may contribute to the pathogenesis of autism. In support of these hypotheses, our preliminary study found that Pacs2 is required for the in vitro differentiation of mouse OPCs, and Pacs2 expression was significantly downregulated in several autism mouse models where myelin deficiency was observed. Moreover, Pacs2 whole-body knockout mice exhibited neurological phenotypes. Currently, little is known about the role of Pacs2 in in vivo OL development and CNS myelination. This project intends to address it by deleting Pacs2 in OL lineage cells through the Cre- loxP approach.

Public health relevance
Project Narrative Myelination of the central nervous system by oligodendrocytes is essential for the development and function of the central nervous system. Impaired myelination causes neurological and neuropsychiatric disorders. This project will elucidate the role of Pacs2, an autism-linked gene, in oligodendrocyte development and central nervous system myelination.